ONCOLOGIC IMAGING

Washington University has a long history of research in the area of imaging. Investigations on the clinical application of the first computed tomography scanner were carried out at Washington University and positron emission tomography was initially developed here. The Oncologic Imaging Program emphasizes the developmental of novel imaging agents for nuclear imaging, MR imaging and optical imaging, as well as the application of a variety of imaging techniques to oncologic problems. The Program's research is focused in the following areas: (1) the development of new imaging agents to assess tumor therapy, 92) the investigation of agents designed to monitor multi-drug resistant modulators, (3) the development of new techniques in the area of molecular imaging, (4) the development of agents initially designed for oncologic imaging and extending their application to therapy with unsealed sources, and (5) the application for modern imaging techniques for the evaluation and planning of radiation treatment. Several research questionnaires are common to all of these areas. A major effort is being made in developing co-registration techniques for the various imaging modalities that can be utilized in small animal models of cancer, large animal imaging as well as human imaging. The Oncologic Imaging Program has the goal of expanding collaboration on the application of imaging techniques to answer specific questions in the other Programs. The Program is applying its expertise in small animal imaging to collaborations with the basic science Programs as well as translating basic science investigation to the Clinical and Translational Research Program.